Center for Quantitative Biology: A focus on "omics", from organisms to single cells Supplement 2

Project Summary / Abstract
Macrophages and granulocytes (e.g., neutrophils) are considered key players in the
pathogenesis of glomerular kidney injury, glomerulonephritis (GN). However, the intra-renal
mechanisms and sub-cellular specificity by which these myeloid cells cause glomerular injury
are not known. This large gap in knowledge stems from the limitations in approaches to capture
and profile these highly heterogeneous cells. For example, neither normal density (NDN) nor
low-density neutrophils (LDN), both implicated in GN, are not captured in scRNAseq studies of
kidneys and urine due to the loss of these cells by sample freezing. Given their heterogeneity
and importance in disease, implementing technologies that define myeloid populations in GN
kidneys and how they interact with renal structural cells is critical for understanding their
pathogenic role. Our spatial transcriptomic data reveal macrophages, NDNs, and LDNs in GN
kidneys, with unique and shared spatial organizations. Using DNA methylation (DNAm) data
from urine cells, we capture both macrophages and granulocytes in GN urine. The overall
objectives in this proposal are to: (i) define myeloid populations in GN kidneys, (ii) identify
pathogenic interactions between macrophages vs. granulocytes with renal structural cells, and
(iii) implement urine DNAm assay to profile myeloid cells in GN. The central hypothesis is that
glomerular interactions with LDNs reflect LN immunopathology and worse kidney function and
that urine DNAm will allow a less invasive approach to evaluate the pathogenic myeloid
populations. The hypothesis will be tested with two specific aims: 1) Define macrophage and
granulocyte populations and their communication pathways with structural cells in GN kidneys
and 2) Quantify and define kidney infiltrating myeloid populations in urine using DNAm. In Aim 1,
single-cell spatial transcriptomics will be used to define in situ myeloid heterogeneity in GN
kidneys by integrating bulk RNA-seq-derived transcriptomic signatures of sorted
subpopulations. Pathogenic interactions with glomerular, interstitial, and tubular endothelial and
epithelial structures will be defined. In Aim 2, macrophages and granulocytes will be quantified
in urine using unique DNAm signatures in relation to kidney function. This research is innovative
because it will propose molecular and cellular pathways involved in glomerular injury as well as
introduce a novel approach to detect pathogenic cell populations via non-invasive urine
analyses. This research is significant because it is expected to provide a scientific rationale for
targeting specific myeloid populations in GN.

Public health relevance
Project Narrative Understanding how myeloid cells mediate glomerulonephritis is essential to elucidating the mechanisms of lupus nephritis, the main cause of morbidity and mortality in lupus patients. This application directly addresses the focus of the NIGMS COBRE Supplement to develop team science projects to address complex clinical and translational research questions. In addition to identifying potential targetable pathways to prevent lupus nephritis flares, these studies will develop a non-invasive approach to define myeloid cell contributions to kidney disease through novel urine DNA methylation approaches, thus addressing the NIH’s mission to enhance health and reduce the burden of illness.